Investigating healthcare for rural females with complex gynecological conditions

Our proposed Research Project valuably builds directly upon the progress and insights obtained in COBRE
Pilot Project Years 1 and 2 regarding healthcare and outcomes for rural females with congenital uterine
anomalies (CUAs, also known as Mullerian Anomalies), a National Institutes of Health (NIH) Sexual and
Gender Minority health disparity research population. CUAs are differences of development of the female
reproductive tract, impacting ~7% of the general female population, resulting in a variety of health concerns
including pregnancy complications, pelvic pain, infertility, and in severe cases, absence of uterus and upper
portion of vagina. Females with CUAs require a range of healthcare expertise related to diagnoses,
treatment and follow up care throughout their lifetime. The proposed project provides a valuable opportunity
to: (1) engage our Billings Clinic CUA patient community in focus groups to expand upon insights obtained
from Year 2 key informant interviews, and to define priorities for future patient-driven research; (2) assess
Mountain West health system administrative records to (a) reveal the prevalence and extent of interstate
travel required to receive care for CUA patients in the Mountain West, and (b) stratify gynecological cancer
risk for women with CUAs according to type of cancer and variation of anomaly; and (3) examine the
financial burdens and insurance barriers related to CUA-related healthcare procedures to reveal the extent
of important compounding disparities in terms of healthcare cost and access to medically necessary
reproductive care for this patient community. Given our ability to continue fostering partnerships with our
CUA patient and provider community, the project will support the continued quantitative and qualitative
analysis of clinical outcomes and patient experiences, and strengthen collaborations with regional patients
and their providers across the Mountain West. Successful completion of our aims will ultimately assure
patients as research partners, foster broader collaboration opportunities with regional providers caring for
these women (including for future recruitment), and reveal valuable clinical data outcomes to support a
competitive R01 submission.

Public health relevance
Females with Congenital Uterine Anomalies (CUAs) require a range of healthcare throughout their lifetime. There is a distinct lack of patient-driven translational research for this health disparity population. Given the compounding disparities in relation to healthcare access and increased risk for comorbidities for females with CUAs, patient-informed qualitative inquiry and quantitative clinical data analyses are required to inform valuable translational guidance for optimum clinical outcomes, and to affirm equitable models of care.